Behavioral Sleep Medicine: Training in Sleep and Aging

ABSTRACT
Goals: Dr. Perlis requests K24 support to: 1) maintain and expand his mentoring of junior investigators in the
area of behavioral sleep medicine (BSM) and in the biopsychosocial approach to the study of insomnia; and 2)
expand his program of research on sleep and aging. Background: Dr. Perlis has been involved in patient-oriented
research since his late-20’s. He has been the beneficiary of exceptional mentorship and has carried forward this
tradition over the entirety of his career. His research, while narrow in focus, extends from basic to patient-oriented
to epidemiologic studies. His work includes 175 peer reviewed articles, 38 chapters, and three books. Four of the
chapters are in our field’s flagship text book, the Principles and Practice of Sleep Medicine. The work has been
highly impactful (H-Index of 68 with over 19,000 citations) and has earned him the SBSM’s Peter Hauri Lifetime
Achievement award, nominations for the SRS’s Mary Carskadon Education Award, and the SBSM’s “Champion of
BSM” Award. Environment: The University of Pennsylvania is one of the nation’s premier centers for sleep and
chronobiology research and sleep medicine / behavioral sleep medicine clinical services. As such, it has much
to offer both the PI and his trainees. Development Activities: The core activity for the mentor’s professional
development will be the implementation of a 2nd generation of monthly seminar series focused on Sleep and
Aging. This series will be co-hosted with Dr. Michael Grander as part of the University of Arizona’s Essential
Topics in Behavioral Sleep Medicine Lecture Series. Leading scientists will be invited to discuss their ideas with
respect to the effects of aging on sleep. These lectures will be offered as video conferences (open to all at no
cost) and will be archived so that they may be accessed into the foreseeable future. During the K24 time frame,
Dr. Perlis will also complete the development of an open access sleep health screener and a sleep tracker app.
Both will be setup to capture data from thousands of individuals. Both will serve as data archives. Research: The
candidate has created a collaborative network to conduct archival analysis with Jr. Investigators using his NIA
supported: 1) natural history of insomnia databases and 2) partial reinforcement of medical treatment of insomnia
databases (n=3). Additionally, his trainees and collaborators will have access to his programs’ recruitment
database (n=5000+), his ISI in psychiatry screening database (n=3,000), a risk benefit network meta-analysis
database (PI: J. Cheung), his newly established screener and tracker databases, and three industry databases
(two of which will be used to profile sleep in patients with Alzheimer’s and Parkinson’s disease; one of which will
be used to profile acute and chronic placebo response in patients with insomnia, with a focus on age effects on
placebo responding). The individuals invited to analyze one or more of the 12 databases will have specialty
areas apart from the PI, and thus will serve as an opportunity for the PI to both teach and learn. A conference
will be held in the 5th year of this award for all collaborators and trainees. Significance: This K24 will support Dr.
Perlis’ efforts to promote and mentor patient-oriented research, with a focus on aging effects on sleep continuity.

Public health relevance
NARRATIVE There are a wide array of negative outcomes associated with sleep disturbance (in general) and insomnia (in specific) including fatigue, cognitive impairment, mood disturbance, impaired daytime function, and diminished quality of life. Beyond these regular daytime effects, sleep disturbance substantially increases the risk for depression, substance abuse, hypertension cardiovascular disease, glucose homeostasis dysregulation, immuno-suppression, overall increased health care utilization, and possibly increased mortality. These associations clearly suggest that there is an urgent need to better characterize sleep disorders symptoms in terms of how they develop and how are expressed over time, both in general, and specifically in the most vulnerable of populations: older adults.